UCSF-UCB Tuberculosis Research Advancement Center (TRAC)

PROJECT SUMMARY
The overall goal of the proposed UC San Francisco – UC Berkeley Tuberculosis Research Advancement Center
(UCSF-UCB TRAC) is to accelerate the pace of discoveries that improve our understanding of tuberculosis (TB)
and lead directly to new tools for diagnosis, prevention, and treatment of TB. Addressing the complex problems
of the current heavy burden and persistence of the TB epidemic requires partnerships across disciplines;
mobilization of technology for identification, intervention, and prevention; and mentoring of future scientists and
clinicians. The UCSF-UCB TRAC is uniquely positioned to address these challenges for radically new
treatments, better diagnostics and an effective vaccine. UCSF and UCB represent a major hub of NIH-funded
TB research with many labs across the wide spectrum of disciplines, and the UCSF-UCB TRAC will fill a critical
gap in a prominent clinical and basic science research environment. Our proposed UCSF-UCB TRAC will allow
us to, (1) attract and support New Investigators (NI) in the TB field by providing pilot awards, training, longitudinal
mentorship and other key services and resources; and (2) attract and enable non-TB investigators to enter the
field by providing awards, key resources and opportunities for multidisciplinary collaboration that support new
directions in TB research. Further, our Center tightly integrates 4 cores: 1) an Administrative Core to provide
leadership, infrastructure, administrative and communication support, advice and oversight to coordinate all
UCSF-UCB TRAC operations; 2) a Basic Science Core to lower traditional barriers experienced by investigators
to facilitate innovative, multidisciplinary, fundamental TB research through a suite of cutting edge technologies
accessible in BSL-3/ABSL-3 facilities; 3) a Clinical Science Core to augment existing UCSF and UCB resources
to accelerate clinical research by engaging new investigators and reducing the barrier to conducting high-quality,
innovating clinical research; and 4) a Developmental Core to attract and develop scientific leaders in TB research
via a platform of services to support a continuum of ideas to independence in TB research, offering mentoring,
professional development, proposal support, and research funding. The UCSF-UCB TRAC will add value to the
robust research enterprises of UCSF and UC Berkeley by bridging traditional silos between fundamental and
clinical TB and by providing a nucleating factor for coordinated TB research resources and collaboration at the
two campuses and at affiliated international research sites.

Public health relevance
PROJECT NARRATIVE The proposed UCSF-UCB TRAC Center will unite and expand the tuberculosis (TB) research programs of UCSF and UCB to accelerate discovery and to develop new ways to detect, prevent and treat TB infection in humans. By creating a program that helps new researchers navigate the unique difficulties of working on this formidable pathogen and that fosters multidisciplinary collaborations, we envision this Center will increase the vibrancy of TB research in the Bay Area and beyond.